Promoting scientific and workforce diversity by enriching the Arkansas Rural Community Health Study (ARCH) among Mother-Daughter Pairs

PROJECT SUMMARY
Residents in Arkansas (AR) face high risks in generational exposure to pesticides and fertilizers from
agricultural production; heavy metals such as arsenic found in the soil, water, air; and aromatic hydrocarbons
(benzene, benzo[a]pyrene) from frequent burning of trash, crop and timber residues, and high-temperature
cooking. Arkansas Rural Community Health Study (ARCH) is the first and the largest epidemiologic cohort of
adult women in AR to examine the effects of both genetic and environmental exposures (EE) on an individual’s
risk of developing breast cancer (BC) and predicted response to treatment. In total, the institutional-supported
ARCH cohort has 26,375 women from all 75 AR counties. In contrast to most cohorts conducted among
populations well below average risk, ARCH is enriched with a high rate of early-onset breast cancer (EOBC)
cases among all BC prevalent cases at baseline and incident cases when linked with Arkansas Cancer Registry.
Given increasing incidence of EOBC nationwide, it is crucial to invest in an understudied rural population with
generations of exposure to identify factors responsible for increasing risk and the mechanisms underlying EOBC
etiology. Our goal is to maintain, enrich, and enable a broader use of data and sample resources for the ARCH
cohort by facilitating longitudinal follow-up since the baseline recruitment 17 years ago. By partnering with the
University of Arkansas for Medical Sciences (UAMS) Translational Research Institute and Rural Research
Network, we will have the unprecedented opportunity to leverage the existing 8 UAMS Regional Campuses to
target recruitment efforts among existing mother-daughter pairs especially in the rural and underrepresented
minority (URM) communities for additional biospecimen and exposure surveys, especially during key windows
of susceptibility. The project will promote widespread data sharing and scientific collaborations, while
strengthening scientific and workforce diversity in environmental health with the goal to 1) expand our
collaboration and hiring of URM faculty and staff, 2) enrich the cohort with environmental constructs and social
determinants of health, 3) follow up existing ARCH participants, focusing on the mother–daughter pairs to
understand generational exposures in the rural state, and 4) develop an interactive dashboard to facilitate data
sharing and sample request. The proposed project will enrich the established ARCH cohort in AR with insurance-
cancer registry databases, EE and biospecimens (saliva, urine, blood - including viable immune cells) since the
baseline recruitment. The collaboration with RRN will ensure enrollment of rural and URM populations and the
target follow-up of mother–daughter pairs will allow future research on generational exposure, modifiable lifestyle
factors, and genetics contributing to EOBC etiology. The implementation of an interactive dashboard will further
facilitate broader use of data and sample resources for future projects to identify interventions on cancer health
disparities, prevention strategies, and to support development and treatment of cancer immunotherapy.

Public health relevance
PROJECT NARRATIVE We seek to support the Arkansas Rural Community Health Study (ARCH) established in 2007 with high rate of early-onset breast cancer among prevalent cases at baseline recruitment. By partnering with the Rural Research Network, this project will follow-up existing mother-daughter pairs especially in the rural and underrepresented minority communities for additional biospecimen and exposure surveys, especially during key windows of susceptibility. The project will promote widespread data sharing and scientific collaborations, while strengthening scientific and workforce diversity in environmental health with the goal to 1) expand our collaboration and hiring of URM faculty and staff, 2) enrich the cohort with environmental constructs and social determinants of health, 3) follow up existing ARCH participants, focusing on the mother–daughter pairs to understand generational exposures in the rural state, and 4) develop an interactive dashboard to facilitate data sharing and sample request.